Protein Glycosylation in the Coagulopathy and Inflammation of Sepsis

SUMMARY
Sepsis is life-threatening syndrome caused by the presence of harmful microorganisms in the blood and
tissues and resulting in host inflammation, coagulopathy and organ dysfunction. As the leading cause of death
in non-cardiac intensive care units, the incidence of sepsis continues to increase while no new effective
therapies have been developed in decades. Among patients, mortality averages 25%, while many survivors
experience long-term disabilities caused by thrombosis, hypoperfusion, and hyperinﬂammation. Globally,
sepsis is more prevalent than cancer with millions of patients and billions of dollars of health care costs
annually. Lack of molecular information of the pathophysiology of sepsis has primarily contributed to the
paucity of new and more effective treatments. This program project renewal proposal continues to address this
problem with novel approaches to advance the knowledge of sepsis from a descriptive to a more molecular
basis. The program retains the expertise of scientists and clinicians whom together are making transformative
discoveries of disease mechanisms and protective strategies targeted by the pathogen and the host in the
onset and progression of sepsis. The proposed program renewal leverages comparative models of
experimental sepsis applied to the discovery of disease mechanisms that rapidly remodel and regulate host
blood and vascular components. Remodeling includes glycosidic and proteolytic processes that cause
profound changes to the half-lives, localization, abundance, and functions of circulating and cell surface
glycoproteins and platelets, linked to the coagulopathy, inflammation, and lethality of sepsis. The program is
integrated by the overall hypothesis that Protein glycosylation and glycoprotein remodeling alter the
coagulopathy and inflammation of sepsis. The three projects and four core facilities proposed will address this
hypothesis with synergistic, interdisciplinary, and state-of-the-art approaches. Aims of the projects and cores
encompass comparative molecular investigations of coagulation factors, tissue thrombosis, inflammation,
serology, and pathogen burden and virulence among blood, urine, and tissue proteomes. Findings thus far
have identified mechanisms that differentially identify and alter sepsis in the context of discrete pathogens
including changes in pathogen virulence, supporting the emerging view that sepsis does not arise from a
singular disease mechanism and may be stratified to achieve diagnostic and therapeutic benefits. Comparative
analyses of experimental and human sepsis will continue as findings thus far have indicated conserved
markers of disease mechanisms linked to stratification by pathogen and patient prognosis. The rationale for the
aims of this program are derived from extensive supporting data and recent peer-reviewed publications.
Additional discoveries that this program is poised to make will enable further advances in the mechanistic
understanding of the life-threatening changes to host blood and vascular systems during sepsis and generate
significant insights needed to develop more effective diagnostics and therapeutics.

Public health relevance
NARRATIVE The coagulopathy and inflammation of sepsis are major causes of human disability and death with a higher incidence worldwide than that of cancer. Death as an outcome averages 30%, underscoring the incomplete knowledge of the molecular pathogenesis of sepsis needed for breakthroughs to address this escalating health problem. This research program leverages the expertise of a successful team of scientists and clinicians whom propose to continue generating transformational discoveries of mechanisms underlying sepsis with the potential to further stratify this disease process while identifying more effective diagnoses and treatments.